Mechanisms and dynamics of superinfection exclusion in microviral prophage populations

Mechanisms and dynamics of superinfection exclusion in microviral prophage populations
PROJECT SUMMARY
The Microviridae, small, single-stranded DNA (ssDNA) viruses that infect bacteria are among the most
abundant and stable colonizers of the human gut. Therefore, competition for host cells between lysogenic
microviruses is expected to be fierce. Hypervariable regions (HVRs) mediating prophage defense against other
viruses (superinfection exclusion, SiEx) as well as overcoming these defenses have evolved numerous times
concurrently with the evolution of lysogeny in different microviral lineages. We thus hypothesize that
microviruses have also evolved one or more entirely novel ways by which they prevent viral superinfections,
and that these mechanisms have profound influence on their genome dynamics. In addition, there is evidence
that these mechanisms might have been adapted by bacteria to become anti-phage defense systems. Our
project’s objectives are thus to understand a) the origin(s) of microviral SiEx and b) the influence of HVR
diversity on SiEx dynamics. To this end, we will compare the basic mechanisms of SiEx in independently
evolved microvirus prophages, a putative defense system, and potential SiEx-like mechanisms in lytic
microviruses that might have served as exaptations in prophage SiEx. Secondly, we will experimentally test the
effect of HVRs on SiEx, in particular whether specific mutations allow the avoidance of SiEx and how different
HVR types interact with each other. This will be done through synthesis of variants of the model microvirus
Enterogokushovirus carrying all known HVR types. Pairwise infection assays will then determine which HVRs
can block or overcome SiEx of other HVRs. This study will provide considerable insights into the biology of the
Microviridae and also insights into the influence of SiEx on the population dynamics of prophages in general.
Additionally, it will contribute to our growing knowledge of the arsenal of phage defense mechanisms in
bacteria.

Public health relevance
Project Narrative It is in a virus’ best biological interest to protect the cells it has infected from simultaneous infection by other viruses. This competition between viruses has led to the evolution of defense systems and means to overcome them. This proposal studies this phenomenon in microviruses, which are among the most abundant viruses infecting bacteria in the human gut, and which might have evolved entirely novel ways to defend against other viruses.